Cancer Center Support Grant

The UPMC Hillman Cancer Center (HCC) at University of Pittsburgh is a matrix cancer center, currently led by Kathryn Schmitz, PhD, MPH who has served as Interim Director of HCC since January 2025. With funding from the National Cancer Institute and other peer- and non-peer-reviewed sources, HCC conducts impactful basic, clinical/translational, and population science research that is changing the way we detect, diagnose, and treat cancer. Through our research and community outreach efforts, we address the needs of cancer patients and those who are at risk of developing cancer in our 29-county western Pennsylvania catchment area. Through our strong efforts in educating and training new cancer researchers and clinicians, we are ensuring that those needs will continue to be met in the years to come. HCC integrates the expertise and resources of the University of Pittsburgh, a top-5 institution in NIH funding, and UPMC, one of our nation’s largest health care systems, to provide our 310 members with state-of-the-art facilities and equipment, and numerous opportunities for interaction and collaboration. Organized into 7 research programs focused on Cancer Biology, Genome Stability, Cancer Virology, Cancer Immunology and Immunotherapy, Cancer Therapeutics, Cancer Epidemiology and Prevention, and Biobehavioral Cancer Control, our members published over 4,000 articles and enrolled more than 12,700 adult and pediatric patients onto interventional clinical trials from 2014-2018. These efforts were enabled by our 10 shared resources and extensive infrastructure for supporting clinical research at central academic and community network sites. HCC is guided by an experienced Senior Leadership Team of Deputy and Associate Directors who join Dr. Schmitz in overseeing our science and operations. With input from the leaders of our research programs and other key HCC members, this team sets the vision and develops the strategic plan for our future development, which includes a new HCC-wide Administrative Core for supporting team science.

Public health relevance
Project Narrative: The mission of the UPMC Hillman Cancer Center (HCC) is to reduce the burden of cancer in western Pennsylvania and the nation through research, patient care, education and outreach. Since its founding in 1985, HCC has been at the forefront in discovery and advancement of scientific findings that have led to new strategies for preventing, detecting, diagnosing, and treating cancer, and for addressing the health-related needs and well-being of cancer patients and survivors.